In vitro pharmacology, chronic toxicology, and embryo-fetal development studies to demonstrate safety of GSM-779690

Project Summary/Abstract
Alzheimer disease (AD) is a chronic neurodegenerative disease that develops over decades, with accumulation
of amyloid-β (Aβ)-plaques that induce neuritic changes; these changes lead to glial inflammatory responses and
to the accumulation of neurofibrillary tangles, whose temporal and regional distribution correlates with cognitive
loss. Consistent with the chronology of the disease, the amyloid hypothesis of AD has been a major focus of
therapeutic efforts. Recently, the refinement of humanized monoclonal antibodies (mAbs) that bind with high
affinity to soluble and insoluble protofibril forms of Aβ to facilitate their removal by Fc receptor-mediated
phagocytosis have been shown to slow disease progression and have validated the therapeutic benefit of
treatment approaches targeting amyloid. Although these new mAb treatments offer hope, the significant costs,
serious side effects, and limited benefit remain major concerns. The use of small molecules aimed at decreasing
total Aβ production by inhibiting BACE-1 or γ-secretase have failed to demonstrate efficacy and often resulted
in adverse cognitive effects, likely due to on-target inhibition of important proteolytic functions. Distinct from
inhibitory strategies, γ-secretase modulation does not inhibit γ-secretase activity, but rather allosterically alters
the cleavage of substrates lowering the net production of Aβ42 (the most pathogenic Aβ species) and Aβ40,
while increasing to the shorter non-fibrillar Aβ38 and Aβ37 peptides. The selective attenuation of Aβ42 using a
small molecule γ-secretase modulator (GSM) represents a safer alternative that targets amyloid than complete
pathway inhibition and may prove to be more effective in delaying or even arresting AD progression. Our goal is
to develop a GSM as a preventative and/or a disease modifying treatment for AD in adults with autosomal
dominant AD (ADAD) and other high-risk populations, such as individuals with Down syndrome (DS) and APOE
ԑ4 homozygotes. We have developed GSM-779690 (compound 3) which exhibits an in vitro IC50 value of 5.3 nM
for the attenuation of Aβ42, displays a good ADMET (absorption, distribution, metabolism, excretion, and
toxicology) profile, and demonstrates excellent in vivo potency (brain Aβ42 levels in mice falls below the limits
of the assay at 10 mg/kg p.o.). Extensive pharmacological/toxicological evaluation, of GSM-779690 is nearing
completion, including definitive Good Laboratory Practice (GLP) Investigational New Drug (IND)-enabling
studies. Preparation of an IND application is underway for filing with FDA in January of 2025. A phase 1 single
ascending dose/multiple ascending dose clinical trial for the evaluation of GSM-779690 in healthy participants is
schedule for March of 2025. To continue the development of this promising therapy, we propose the conduct of
phase II-enabling studies, including a 6-month chronic toxicology study with recovery in rats, embryo-fetal
development (EFD) toxicity studies in rats and rabbits, and in vitro safety pharmacology studies. Successful
completion of these studies will support the advancement of GSM-779690 to phase 2 clinical evaluation as a
potential treatment for AD, moving this critically needed therapy closer to the clinic.

Public health relevance
Project Narrative Alzheimer’s disease (AD) researchers at UCSD are developing a potential treatment for AD which they eventually hope to test in phase 2 clinical trials for its ability to: a) prevent the disease from occurring in high-risk genetically predisposed subjects (primary prevention); and b) slow down the rate of disease progression in AD patients who are in the very earliest phases of the disease (secondary prevention). Currently, UCSD is preparing to begin a phase 1 single ascending dose and multiple ascending dose safety and tolerability study of a new drug (GSM-779690) in healthy normal subjects planned to begin in March of 2025. Prior to moving from phase 1 to phase 2 clinical trials, a 6-month GLP safety and toxicity study in rats, embryo-fetal development (EFD) toxicity studies in rats and rabbits, and in vitro safety pharmacology studies must first be completed and represent the objectives of this proposal.